Central Cardiovascular Regulation: Role of Urocortin III

DESCRIPTION (provided by applicant): DESCRIPTION (provided by applicant): Urocortin III belongs to the corticotropin releasing factor (CRF) family of peptides which are known to play an important role in the regulation of autonomic, endocrine and behavioral responses to stress. Urocortin III mediates its actions via CRF-2 receptors and it has been suggested that it may be the endogenous ligand for these receptors. Neurons containing urocortin III are located primarily in the hypothalamus. Within the hypothalamus, urocortin-III neurons are distributed mainly in the paraventricular nucleus and the perifornical area lateral to this nucleus. Urocortin III has been implicated in several physiological functions including regulation of feeding and stress responses. Adjustment of cardiovascular responses is one of the mechanisms for coping with stress. Since urocortin III has been identified relatively recently (2001), little is known about its cardiovascular actions. There is only one report in the literature in which intracerebroventricular injections of stresscopin (structurally almost identical to urocortin III) were shown to elicit increases in blood pressure and heart rate. A clear understanding of the central cardiovascular actions of urocortin III is a prerequisite for unraveling the mechanism of cardiovascular responses of this peptide in stress. The hypothesis central to this project is that urocortin III is excitatory to neurons located in medullo-spinal cardiovascular regulatory regions. The hypothesis is based on our preliminary results in which it was demonstrated, for the first time, that urocortin III may play a role in medullo-spinal cardiovascular regulatory areas. The overall goal of this project is to characterize and understand the mechanism of cardiovascular actions of urocortin III in selected medullo-spinal cardiovascular regulatory areas including the medial subnucleus of the nucleus tractus solitarius (mNTS), the caudal ventrolateral medullary depressor area (CVLM), the rostral ventrolateral medullary pressor area (RVLM), the nucleus ambiguus (nAmb) and the intermediolateral cell column of the thoraco-lumbar spinal cord (IML). A multi-disciplinary approach, involving physiological, pharmacological and electrophysiological techniques, will be used to accomplish these aims. The central nervous system plays a significant role in development and/or maintenance of some cardiovascular disorders associated with stress. Substantiation of our preliminary results regarding cardiovascular effects of urocortin III will eventually be helpful in understanding the mechanisms involved in cardiovascular disorders associated with stress and developing novel regimens of treatment for combating deleterious cardiovascular effects of stress.

Public health relevance
PROJECT NARRATIVE The brain plays a significant role in the development and maintenance of some cardiovascular disorders associated with stress. Urocortin III is a new stress hormone found in the human brain. The present proposal is designed to characterize the mechanisms of cardiovascular actions of urocortin III in different regions of the hind brain and spinal cord. Completion of this research will eventually be helpful in understanding the mechanisms involved in cardiovascular disorders associated with stress and developing rational treatment for ameliorating the harmful cardiovascular effects of stress. __SpecificAimsTextDelimiter__ ABBREVIATIONS: Abbreviations are spelled out in the text and also listed at the end of Section D (Research Design and Methods). A. SPECIFIC AIMS Initial autonomic, endocrine and behavioral responses to stress provide a short-term metabolic lift to an individual [44]. These responses are initiated by the stress-induced release of corticotropin-releasing factor (CRF) in the hypothalamus [3, 4]. CRF reaches the anterior pituitary via the hypophyseal portal system, activates corticotropin-releasing factor type 1 (CRF-1) receptors on the corticotropic cells and adrenocorticotropic hormone (ACTH) is released into the circulation. ACTH elicits secretion of cortisol (corticosterone in rats) from the adrenal cortex. Cortisol promotes gluconeogenesis, and protein and fat mobilization in order to make adjustments for stress-induced responses [3, 4, 46]. Prolonged and inappropriate stressful situations can perturb homeostasis which may lead to disease [44]. Urocortin III (UC III) is the latest addition to the CRF peptide family [44, 60]. This peptide is present in the hypothalamus [61] and has been implicated as one of the endogenous ligands involved in stress responses [51]. One of the mechanisms for coping with stress is adjustment of cardiovascular responses to stress. Since urocortin III has been identified relatively recently (2001) [44, 60], little is known about its cardiovascular actions. There is only one report in which intracerebroventricular (i.c.v.) injections of stresscopin (which is structurally almost identical to urocortin III) have been reported to elicit transient increases in blood pressure (BP) and heart rate (HR) in conscious rats via activation of sympatho-adrenal medullary system [22]. An understanding of the central cardiovascular actions of urocortin III is a prerequisite for unraveling the mechanism of its actions during stress. The goal of this project is to characterize the mechanism of cardiovascular actions of urocortin III in selected medullo-spinal cardiovascular regulatory areas. The hypothesis central to this project is that urocortin III is excitatory to neurons located in these medullo-spinal regions. This hypothesis is based on our preliminary results in which it was demonstrated, for the first time, that medullo-spinal cardiovascular regulatory areas may play a role in mediating the cardiovascular actions of urocortin III (preliminary results are presented under each proposed aim in Section D). Other peptides of the CRF family are not included in this proposal in order to keep the application focused. The proposal has following five specific aims: Aim-I. To study the mechanisms of cardiovascular actions of urocortin III in the medial subnucleus of the nucleus tractus solitarius (mNTS). Aim-II. To study the mechanisms of cardiovascular actions of urocortin III in the caudal ventrolateral medullary depressor area (CVLM). Aim-III. To investigate the mechanisms of cardiovascular actions of urocortin III in the rostral ventrolateral medullary pressor area (RVLM). Aim-IV. To investigate the mechanism of cardiovascular actions of urocortin III in the nucleus ambiguus (nAmb). Aim-V. To investigate the mechanism of cardiovascular actions of urocortin III in the intermediolateral column of the thoracic cord (IML).